Recovery Housing for Alcohol and Drug Use Disorders: A National Study of Availability, Characteristics, and Factors Associated with Evidence-based Practices

Safe and stable housing is essential to recovery from addiction to alcohol and drugs. Recovery housing
represents a unique and innovative way to ensure that individuals in recovery have access to housing that
facilitates it. A growing body of research supports the effectiveness of recovery housing, and findings to
support recovery housing evidence-based practices are beginning to emerge. However, there are critical gaps
in our understanding of recovery housing. The recovery housing literature is fragmented, focusing on certain
types of recovery housing or recovery housing in specific geographic regions. We also lack tools necessary to
provide a complete picture of the national recovery housing landscape. To address these gaps, the aims of this
4-year health services research proposal are to: (1) Examine availability of recovery housing in the US and
characterize environments where recovery residences are located; (2) Characterize the national recovery
housing landscape in terms of organizational and residence characteristics, policies, practices, programming,
and service delivery orientation and explore whether these characteristics vary depending on where
residences are located; (3) Identify underlying patterns among recovery residences and examine the
association between these patterns and existing categorizations of treatment and recovery housing; (4)
Explore organizational, residence, policy, practice, programming, and delivery orientation characteristics
associated with recovery housing evidence-based practices. To address these aims, we will consult with a
diverse group of experts in the treatment, recovery, housing, and recovery housing fields to create a national
database of recovery residences and survey of a random sample of 800 residences stratified by state. All
residences in the database will be geocoded and linked with contextual information, including data on alcohol
and drug treatment availability, alcohol outlets, and crime. The survey will collect critical data on organizational
and residence features, policies, practices, programming, and service delivery orientation to illustrate essential
features of recovery housing and to delineate different types of it. The proposed study will constitute the largest
and most diverse study of recovery housing to date, laying the groundwork for surveillance of this important
component of the housing, treatment, and recovery support services landscape. It will provide much needed
descriptive data on a nationally-representative sample of recovery residences, and it will facilitate large-scale
national studies of recovery residences, comparative effectiveness and cost-effectiveness studies of different
types of recovery residences, studies identifying type sort of recovery residence works best for whom, and
studies of policies and organizational practices that increase recovery housing access and utilization.

Public health relevance
Addiction to alcohol and drugs is a pervasive public health problem with well-documented consequences. Recovery housing is a promising way to improve outcomes among those in recovery, but critical gaps in the scientific literature remain because we lack key information about the availability and nature of this recovery resource. By developing a national database of recovery residences and surveying a stratified random sample of residences across the country, this application will significantly enhance our understanding of this component of the service delivery system.